Surveillance Core

Summary/Abstract
Significant progress in malaria control has been realized in the last decade due to increased access to
proven malaria control interventions, including insecticide-treated bed-nets, indoor residual spraying with
insecticides, improved case management with artemisinin-based combination therapies, and use of drugs
to prevent malaria in high-risk groups (chemoprevention). With the improved control, reliable surveillance is
essential to monitor the impact of control interventions. Our existing PRISM program has conducted
comprehensive malaria surveillance using different methodologies across a variety of epidemiological
settings in Uganda. This work has greatly contributed to our understanding of optimizing approaches to
malaria surveillance in Uganda and other malaria endemic countries. Building on experience gained, we
propose to continue key components of our malaria surveillance work with more intensive longitudinal
evaluations as part of a shared resources core (Surveillance core). We will add new activities to provide
more detailed and precise data that will be used to monitor trends in the burden of malaria, estimate the
impact of control interventions, and provide clinical data and specimens for our three inter-related research
projects (Resistance, Epidemiology and Transmission projects). We will conduct health facility-based
malaria surveillance at 21 government health centers throughout Uganda where different population level
control interventions are being implemented to monitor trends in malaria epidemiology. Individual level data
will be collected from all patients who present to the outpatient departments including whether they have
suspected malaria, whether they underwent laboratory testing for malaria, the results of laboratory testing,
and antimalarial prescription practices. In addition, we will periodically collect specimens from these sites
for the testing of markers of drug and insecticide resistance as part of our Resistance project. We will also
conduct detailed longitudinal cohort studies in 3 sites with differing malaria epidemiology to measure the
incidence of malaria, and collect clinical data and biological specimens to support our three research
projects. Finally, we will conduct detailed entomological surveys at our longitudinal cohort sites to generate
data on the intensity and characteristics of transmission at the individual household level as well as provide
mosquito specimens to be used in our three research projects.